The Role of Bilingualism in Cognitive and Brain Resilience: Addressing the Complexity

PROJECT SUMMARY / ABSTRACT
Bilingualism may protect against cognitive and brain changes in both healthy aging and Alzheimer’s disease
and related dementias (ADRD) through enhanced executive functioning, arising from the need to constantly
manage two or more languages. However, studies have yielded mixed results, and there remains an unknown
role of bilingualism in 1) resistance to the development of neuropathology and in 2) resilience, the maintenance
of cognition and/or brain structure in the presence of neuropathology burden. Further research to clarify the
protective role of bilingualism in aging and ADRD is crucial and highly relevant, considering that over half of the
world’s population and more than 20% of the US population speak two or more languages. This proposal will
help clarify the role of bilingualism in healthy aging and in Alzheimer’s dementia (AD) by addressing the
nuances underlying bilingualism, sociocultural factors, executive functioning, and dementia diagnoses. We
hypothesize that bilingualism contributes to resistance and resilience through both network-specific (language
and executive functioning) and domain-general effects, and its impact is moderated by bilingualism and
sociocultural factors, type of executive functioning task, and AD variant. Our long-term goal is to develop a
framework for bilingualism’s influence on resistance and resilience. We will leverage a well-characterized,
prospectively studied cohort of monolingual and bilingual speakers at the UCSF Memory and Aging Center
who span the range of healthy aging (N = 200) and AD variants (N = 400). This cohort is unique in its scope of
longitudinal (2+ timepoints) neuropsychological, bilingualism/sociocultural, neuroimaging, and AD biomarker
data. In Aim 1, we will determine which aspects of bilingualism contribute to a protective effect on executive
functioning. We will group healthy aging and AD variant bilingual speakers based on bilingualism and
sociocultural factors and assess for differences on cognitive measures and neuroimaging findings. In Aims 2
and 3, we will determine if bilingualism is associated with resistance and resilience by comparing monolingual
and bilingual speakers within healthy aging and AD variant groups. We will test for differences between groups
in grey matter (GM) volume and white matter (WM) integrity (Aim 2) and AD proteinopathy (Aim 3) and
correlate the findings with performance on cognitive measures. We are well-suited to complete these aims
given our exceptional multidisciplinary team with expertise in the neural underpinnings of language, clinical
phenotyping of aging and AD, cognitive resilience, and multimodal imaging. Accomplishing these aims will
significantly impact the field of ADRD research by give important insight into the neural basis of bilingualism
and its influence on the trajectory of healthy aging and ADRD, thereby improving care for individuals with
diverse language backgrounds.

Public health relevance
PROJECT NARRATIVE The overarching goal of this multidisciplinary study is to provide a framework for bilingualism’s effect on the trajectory of healthy aging and Alzheimer’s disease, while accounting for the complexity underlying language experiences, executive functioning measures, and dementia types. The findings will improve care for people with diverse language backgrounds and give important insight into whether speaking more than one language can help prevent or slow the symptoms of Alzheimer’s disease and related dementias (ADRD).